Michigan Center for Contextual Factors in Alzheimer's Disease (MCCFAD)

Michigan Center for Contextual Factors in Alzheimer's Disease (MCCFAD) aims to foster and
enhance innovative research in Alzheimer's disease and related dementias (ADRD) with the
long term goals to 1) advance ADRD-relevant social and behavioral science research in
underserved and underrepresented communities while; 2) diversify the research workforce
dedicated to healthy aging. This center will build on the existing deep infrastructure and
research strengths in dementia and aging research at the University of Michigan (UM). The
MCCFAD will emphasize research in three priority areas of: epidemiology, health economics,
and culturally sensitive care. The rationale for these three areas is directly related to the current
lack of a comprehensive understanding of the contextual complexities inherent in ADRD
disparities, the need to enhance diversity in the professional research workforce addressing the
brain and cognitive health of older adults, as well as dynamic changes in the demographic and
multi-cultural composition of the U.S. population. The MCCFAD will promote diversifying the
research workforce dedicated to healthy aging through collaborations with other NIA-sponsored
Centers and programs and via connections with R1, R2 and R3 universities in Michigan. The
Center will focus on the contexts in which ADRD is experienced. Knowledge concerning the
contexts of ADRD is quite limited but has been shown to be critical for elucidating sociocultural,
economic and behavioral contributors to and consequences of health disparities generally and
ADRD disparities specifically. The Center's four Cores are: Administrative (AC), Research and
Education (REC), Analytic (AnC), Community Liaison and Recruitment (CLRC) with the
following specific aims: Aim 1: Advance ADRD-relevant disparities research in epidemiology,
health economics, and culturally-sensitive care; Aim 2: Recruit and mentor 15 AD-RCMAR
Scientists (RS) from the pilot-study investigator stage through professional publications and
independent research applications and funding; Aim 3: Connect with African American, Arab
American and Latino communities to broaden understanding of intra- and inter-cultural factors
affecting participation in ADRD research. The Center profits from the groundbreaking,
successful work of their extensive network of experienced mentors and experts. These
resources, along with planned structure and activities will ensure that, upon receiving NIA
designation as an AD-RCMAR, the MCCFAD will have a significant impact in diversifying the
research workforce dedicated to healthy aging while enhancing research to better understand
AD and related forms of dementia across various contexts.

Public health relevance
OVERALL PROJECT NARRATIVE The Michigan Center for Contextual Factors in Alzheimer's Disease (MCCFAD) will focus on the social and behavioral dynamics in which Alzheimer's disease and related dementias (ADRD) are experienced. To address ADRD, one of the fastest growing health problems in the United States, the MCCFAD builds on longstanding strengths at the University of Michigan in 1) dementia research; 2) mentoring scientists from underrepresented backgrounds; 3) partnerships with Michigan NIA Centers; and 4) links to Michigan's two other major research universities, Michigan State University and Wayne State University. The MCCFAD will lead a coordinated effort to advance health disparity research in three priority areas: epidemiology, health economics, and culturally sensitive care, focusing on African Americans, Arab Americans and Latinos. The goal is to diversify the research in and workforce dedicated to ADRD among underserved and underrepresented communities.